Innate sensing of M. tuberculosis by alveolar macrophages

PROJECT SUMMARY
Mycobacterium tuberculosis (Mtb), the causative agent of Tuberculosis (TB) is one of the leading causes of
death globally by a single infectious agent. There continues to be an urgent and unmet need for new drugs,
diagnostics, vaccines, and host-directed therapies for TB. Two critical events that occur early after Mtb aerosol
transmission are the confinement of the initial inoculum into alveolar macrophages (AM), the first cells infected
in the lung, and the slow establishment of T cell priming and the adaptive immune response. These two features
highlight the importance of early recognition by the host in affecting the course of TB disease and the significant
role of lung-resident AM in initiating the host immune response. As innate airway sentinels, AM must recognize
Mtb bacilli and respond quickly in order to recruit other innate cells to the site of infection, including cells that will
transport bacteria to the draining lymph node for T cell priming. We have previously shown that upon infection
with Mtb in vivo, AM mount an Nrf2-dependent cell-protective, rather than pro-inflammatory, response that
impedes an effective host response and contributes to early Mtb replication. However, the AM response to Mtb
also has plasticity. We observed that mycobacterial exposure, either through BCG vaccination or a contained
Mtb infection, leads to AM cell-intrinsic and durable remodeling, including up-regulation of Interferon Response
Genes and a robust pro-inflammatory response to Mtb, that is associated with an accelerated host response and
enhanced bacterial control after Mtb challenge. The objective of this proposal is to evaluate mechanisms that
restrain or enhance AM responses to Mtb to better understand the regulation of the early events during infection.
In Aim 1, we will categorize AM sensing abilities and defects using both ex vivo and in vivo delivery of Mtb-
related Pathogen Associated Molecular Patterns (PAMPs), and screen for novel negative regulators of AM innate
sensing using a CRISPR-Cas9 knockout library. In Aim 2, we will determine how Type I and II Interferons regulate
AM innate responses using in vitro models and in vivo cell transfer approaches. In Aim 3, we will evaluate how
alterations in AM sensing by Type I and II Interferons impact downstream events in Mtb infection by measuring
changes to innate cell recruitment, transfer of bacteria to the draining lymph node, T cell priming, and AM antigen
presentation in murine aerosol Mtb infection and a macrophage-T cell co-culture system. The studies are
motivated by the hypothesis that the hypo-inflammatory response of AM during Mtb infection is a result of the
reliance on AM as the initial Mtb sentinel, a function for which they are impaired, and the absence of early
systemic signals such as Type I and II Interferons, for which AM are highly sensitive. A better understanding of
the regulation of AM during Mtb infection will inform development of new vaccines and host-directed therapies.

Public health relevance
PROJECT NARRATIVE Alveolar macrophages are lung-resident myeloid cells that serve as innate immune sentinels for Mycobacterium tuberculosis (Mtb), a pathogen that claims more than 1.5 million lives each year. Following aerosol transmission, alveolar macrophages in the airway must recognize Mtb bacilli quickly and initiate the host immune response, yet it is not entirely known how innate sensing is regulated in these cells and what impact it has on disease outcomes. This project aims to characterize alveolar macrophage innate sensing in the context of Mtb infection by identifying defects in specific sensing pathways, testing candidate negative regulators, screening for novel regulators, and evaluating AM modulation by Type I and II Interferons in order to identify new therapeutic targets.